CORE--BEHAVIORAL TECHNOLOGY SUPPORT

This core will enhance the operations of the six projects and Shared Instrument core by providing a number of interlinked services that will help program project staff: (1) obtain better access to resources available at the current field sites in which data are collected; (2) increase the pool of participants that are available at those sites for study; (3) increase the number of schools that make their students available to the research program; (4) develop programming options to manage idiosyncratic individual responding and/or behavior problems; (5) refine established teaching procedures to increase their effectiveness; (6) more effectively disseminate teaching methods and principles developed in the research to potential consumers (i.e., fellow behavioral scientists, special educators, applied behavior analysts, etc.), and (7) implement aspects of the individual projects that point directly to applications of the research. The unifying theme of these services is that all are interrelated elements of our emerging behavioral technology for teaching and evaluating people with developmental disabilities.